Apolipoprotein E4-related Electrophysiological and Metabolic Impairments in Aging and Alzheimer's Disease

PROJECT SUMMARY
The complexity and multifactorial nature of Alzheimer's disease (AD) pose unique challenges for mechanistic
studies and developing therapies. Age is the major risk factor for AD, and imaging and biomarker data suggest
that the pathophysiological processes of AD begin more than a decade before dementia is diagnosed.
Apolipoprotein (apo) E4, the major genetic risk factor for AD, lowers the age of onset in a gene dose–dependent
manner. In most clinical studies, apoE4 carriers account for 60–75% of AD cases, highlighting the importance of
apoE4 in AD pathogenesis. Longitudinal studies show that apoE4's detrimental effect on cognition depends on
age and occurs before typical signs of AD arise. A challenge in AD research is to fully understand how risk
factors, including apoE4 and age-related prodromal processes, interact to contribute to AD pathophysiology.
This proposal is based on intriguing preliminary findings. First, in brain hippocampal slices, intrinsic gamma
oscillations are impaired in apoE4 knock-in (KI) mice at 7 months of age, indicating impaired local network
function. Second, apoE4 expression disrupts mitochondrial respiration and increases production of reactive
oxygen species, likely resulting in oxidative stress and neuronal ATP depletion. Third, neuronal hypometabolism
self-perpetuates, causing network alterations such as hyperexcitability responsible for increased seizure
susceptibility of apoE4-KI mice and rendering the brain especially vulnerable to additional stresses induced by
AD-associated amyloid-beta (Aβ) peptide, the production of which is known to be increased under metabolic
crises. In addition, recent publications from my collaborator lab show that expression of apoE4 in female mice
causes age-dependent impairment of GABAergic interneurons in the hippocampus, and that this impairment is
associated with reduced slow gamma activity and correlates with the severity of learning and memory deficits.
Understanding the mechanisms behind age-dependent apoE4 disruption of network function and the underlying
metabolic pathology will help advance the preventative strategies for people at risk for AD.
This proposal aims (1) to determine the effect of aging on apoE4 disruption of hippocampal network function
and its relationship with GABAergic interneuron impairment, (2) investigate cell-specific effects of aging on
apoE4-induced alterations in neuronal energy metabolism and their effects on network function, and (3)
determine the age-dependent effects of apoE4 on cell type-specific susceptibility to Aβ toxicity. The outcomes
of the proposed study will shed light on primary mechanisms of apoE4-induced pathological aging and dementia,
as well as on synergistic effects of apoE4 with other AD-related factors that contribute to pathogenesis of late-
onset AD.

Public health relevance
PROJECT NARRATIVE This project aims to determine the interactive effects of aging and apoE4 on disruption of hippocampal network function and its underlying energy metabolism, as well as how these impairments predispose the brain to amyloid-beta toxicity and AD initiation. The proposed studies will uncover the interactions between aging and apoE4 in AD pathogenesis and will help advance the development of preventative strategies for people at risk for AD.